Core A: Immune Function Studies

ABSTRACT – CORE A Core A will perform testing to evaluate post-transplant immune reconstitution in patients (supporting Project 1) and in X-SCID and PK dogs (supporting Projects 2 & 3) undergoing hematopoietic cell transplantation (HCT) or gene therapy. The Core will evaluate effector T cell, regulatory T cell, and B cell recovery and differentiation, will measure serum BAFF & April levels, and will evaluate immune cell signaling and function. In addition, the Core will work with the Seattle Children's Immunology Diagnostic Lab (IDL) to evaluate functional immunity in patients and transplanted dogs by measuring disease-specific recovery of immune function and responses to vaccination with the neoantigen Bacteriophage φX174. The core is designed to fully support the proposed observational studies of immune reconstitution after HCT in up to 30 patients each year for project 1 and in all transplanted and gene-therapy treated X-SCID and PK dogs for projects 2 & 3. Data from these analyses will be used to define the course and extent of post-HCT immune reconstitution and will be correlated with the results from clinical evaluations, laboratory testing, graft outcomes, and GVHD to determine the efficacy of the proposed transplant and gene therapy approaches outlined in projects 1, 2, and 3.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT – CORE A This Core laboratory will evaluate how the immune system recovers after bone marrow transplant in patients who have life-threatening, non-cancerous disorders. Specifically, the lab will measure not only the numbers of immune cells as they develop after transplant, but will also evaluate how those immune cells function and whether they are able to offer adequate protection against infection. These studies are critical to determining whether the proposed bone marrow transplant and gene therapy approaches are effective.